Large-scale fine mapping of brain morphometry in bipolar disorder and major depression

ABSTRACT
Bipolar disorder (BD) is a chronic illness in which nearly half of all patients attempt suicide and no biological
measures exist to reliably guide diagnosis or treatment. This project builds off 15 years of successful team
science, reviving existing and independently collected neuroimaging and clinical data from around the world to
create the largest studies of BD and the brain. In this new initiative from the Enhancing Neuro Imaging Genetics
through Meta-Analysis (ENIGMA) Consortium Bipolar Disorder Working Group (ENIGMA-BD), we will apply a
recently standardized method for large-scale voxel-wise brain mapping to improve replication and generalizability
BD-related brain signatures, its clinical factors, and transdiagnostic comparisons to major depressive disorder
(MDD). The ENIGMA-VBM (Voxel-wise Based Morphometry) Pipeline includes built-in voxel-wise processing,
quality control, and analysis tools for both pooled mega- and federated meta-analysis. Whereas most prior
ENIGMA studies have used region of interest measures in which local brain variations are averaged across
parcels of the brain defined by anatomical atlas, ENIGMA-VBM quantifies whole-brain, atlas-free variations at
the voxel level. This new direction allows for focal mapping across the entire brain, including frequently omitted
structures such as the cerebellum. Aim 1 will compute ENIGMA-VBM measures across a target sample of 3,500
BD and 8,500 healthy controls, and analyze focal morphometric patterns associated with BD diagnostic
subtypes, illness severity, polypharmaceutical treatment effects, and other important clinical factors such as age,
sex, age of onset, and comorbid substance abuse. Aim 2 will derive VBM features from the ENIGMA-Major
Depressive Disorder Working Group (ENIGMA-MDD) and identify overlapping and distinct voxel-wise patterns
across the largest samples of BD and MDD ever studied (N=22,500). Interactions between transdiagnostic brain
variations and key clinical factors such as age of onset, duration/severity of illness, number of overlapping/distinct
mood episodes, and pharmaceutical treatment will be assessed. The project represents a new phase of the
ENIGMA Consortium and will create a novel set of atlas-free brain phenotypes to empower the largest
transdiagnostic neuroimaging studies of BD, MDD and beyond.

Public health relevance
NARRATIVE A critical barrier to improving bipolar disorder (BD) diagnosis and treatment is a lack of predictive brain markers that differentiate BD from other related disorders and their treatments. Large-scale mapping of transdiagnostic brain signatures across BD and major depressive disorder (MDD) could reveal how overlapping and distinct symptom profiles, treatments and clinical profiles are related to variations in brain morphometry. This project leverages the global ENIGMA Consortium, pooling large-scale neuroimaging and clinical data on thousands of individuals with BD and MDD, and applies a recently standardized voxel-wise brain mapping procedure to create more replicable and generalizable transdiagnostic signatures of BD and MDD.